The SafeCare@Home4Kids Learning Lab: Designing Safer Healthcare at Home for Children

PROJECT SUMMARY/ABSTRACT
Children with medical complexity are a growing population of medically fragile patients with disability.
Children with medical complexity experience ~70% of unplanned hospital readmissions and have a 10x
higher odds of mortality compared to other children. These children’s daily survival requires parents and home
nurses to safely administer intricate medication regimens through implanted devices, such as a tube inserted
into the stomach. While we know that medication errors or device-related adverse events are happening
at home, no home healthcare reporting or response standards exist to address and prevent them.
Voluntary reporting does not equitably capture events in children of minority backgrounds or necessarily
address prevention. Parents express fear of losing their child’s nursing care or their child’s custody if they raise
safety concerns, especially those of racial minority backgrounds. While home is an essential healthcare site for
CMC, no scientific approaches exist to make sure healthcare safety events do not happen at home. There is a
critical need to identify, communicate, and prevent safety errors and adverse events that occur in the home by
diverse parents and home healthcare providers in a manner that will make sure the children are okay, notifies
the children’s care providers, prevents recurrence, and is equitable to all patients and families.
Our specific aims are to 1) construct the SafeCare@Home4Kids multidisciplinary lab of experts,
including in patient safety, human factors engineering, nursing, pediatrics, HHC, informatics, and lived family
experience to work together to design innovative, effective, and equitable approaches to prevent healthcare
safety errors and adverse events experienced by diverse CMC at home; 2) determine how family caregivers
and home nurses currently identify, communicate, and prevent medication and device-related errors
and adverse events in the context of the home work system; and 3) co-design, implement, and evaluate a
safety toolkit that addresses these elements of medication and device safety using input from families, home
nurses, prescribing providers, and our lab experts, to improve patient safety at home.
Our pediatric PSLL will be an innovative paradigm shift in safety research by focusing on the home as a
fundamental healthcare practice setting for CMC. This work is significant because SafeCare@Home4Kids
serves intersecting AHRQ priority populations who may not otherwise be empowered or supported to
address the safety of their healthcare and addresses common reasons children with medical complexity
use the emergency department or are hospitalized. By using a human factors engineering approach with
national interdisciplinary experts, partnering with patient family leaders, and recruiting a linguistically and
racially diverse participant population, we will advance whole-person 360-degree by equitably impacting the
safety of care no matter where a child calls home.

Public health relevance
PROJECT NARRATIVE The healthcare system does not currently provide ways to identify and reduce healthcare safety threats, such as medication errors and device complications, that occur in the homes of children with complex medical conditions, especially for children from minority groups. This research will bring together experts, including diverse families, for a long-term, equity-focused collaborative Patient Safety Learning Lab that co-designs ways to identify, communicate, and prevent safety events that occur to children with complex medical conditions at home.